Advancing CKD Risk Prediction: Exome-Wide Studies and Rare Variant Analysis Across Big Biobanks

Project Summary/Abstract
Chronic kidney disease (CKD) affects 10-13% of the global population, contributing to mortality,
morbidity, and high public health costs. The polygenic architecture of CKD has been investigated
using genetic data generated in large population-based cohorts. Genome-wide association
studies (GWAS) of cross-sectional eGFR (estimated glomerular filtration rate) have identified
hundreds of variants associated with renal function. One way that GWAS results are clinically
translated involves the development of genome-wide polygenic scores (GPS), which aggregate
the effects of multiple GWAS variants to assess an individual's disease risk. However, a major
limitation of this approach is that the impact of rare protein-coding variants, which tend to have
much larger effects on biology and disease risk, is not detectable by GWAS. Therefore, exome-
wide rare variant association studies are needed to improve the predictive performance of GPS
and better understand the impact of protein-coding genetic variants on kidney function. This
proposal aims to perform large-scale rare variant analyses involving 1 million participants by
leveraging phenotypic and genetic data from major biobanks, including the UK Biobank, All of Us
(AoU), Genomics England (GE), and the Pakistan Genome Resource (PGR). In Aim 1, we will
conduct EXWAS for kidney function across these biobanks, identifying rare variants and genes
associated with CKD while uncovering genetic loci missed by traditional GWAS. In Aim 2, we will
develop a rare variant burden score and integrate it with the existing CKD GPS based on GWAS.
We will test whether the GPS modifies the effect of the rare variant burden score to improve the
overall predictive performance of GPS in CKD. After completion, this project will provide deeper
insights into kidney function's genetic architecture, uncover novel mechanisms underlying CKD,
and enhance the risk prediction of CKD.

Public health relevance
Project Narrative Chronic kidney disease (CKD) affects millions of individuals worldwide, contributing to significant morbidity and mortality. This project aims to investigate rare genetic variants associated with kidney function by leveraging data from big biobanks with phenotype and genetic information. The study aims to enhance CKD risk prediction by integrating rare and common variants associated with kidney function.